Admin

CORE A – ADMINISTRATION
ABSTRACT
The primary goals of Core A – Administration are to provide leadership, logistical support, and coordinated
communication for all Program members and collaborators in order to expedite the successful completion of
the Program’s scientific aims. The PI of Core A is Douglas Yee and the Co-I is Reuben Harris. The specific
aims of the Core are to 1) provide strong and consistent leadership; 2) provide services to Program scientists,
collaborators, and External Advisory Board members; and 3) coordinate Program communications including
meetings, workshops, and outreach efforts. The efficient administration of this bi-institutional, multi-investigator
Program is essential to its success and has proved to be effective over the 7 years that this team has been
working together.
Yee and Harris both have experience managing multi-investigator, matrixed grants, and they meet monthly
to coordinate Program management. They are supported by a Program Manager, Jane Balster, who provides
day-to-day administrative support and coordinates meetings, workshops, and other communication and
outreach activities. The Executive Leadership Team, which consists of Project and Core PIs, meets monthly to
review the status of scientific progress and budgets. In-person Program Workshops, which include Project and
Core PIs, Co-Is, postdocs, graduate students, and other personnel, will continue to be held twice each year,
alternating between the University of Minnesota (fall) and University of California San Diego (spring). The
External Advisory Board, which consists of 5 expert scientists and 3 patient advocates, regularly participates in
weekly meetings and meets twice each year in conjunction with the bi-annual in-person Program Workshop.
Additional meetings of PIs, Project personnel, Core personnel, outside collaborators, and all Program-associated personnel occur on a weekly or monthly basis. Web-based conferencing facilitates the participation
of team members who are geographically dispersed.

Public health relevance
CORE A – ADMINISTRATION NARRATIVE Core A – Administration provides critical support for all administrative activities of the Program, including budgetary and fiscal operations, logistical assistance, and reporting activities. Core A strives to facilitate scientific progress toward the overall goal of diagnosis and treatment of patients with APOBEC-driven breast cancer. It does so by providing strong and consistent leadership; productive administrative services to Program scientists, collaborators, and External Advisory Board members; and coordinated Program communications across all relevant sites, which will include meetings, workshops, and outreach efforts.